An exercise intervention to Reduce Neuropathic Pain and Brain Inflammation after Spinal Cord Injury

Spinal Cord Injury (SCI) leads to alterations in brain structure and function by spinal nerve
damage, secondary inflammatory responses, and by the consequences of living with paralysis
and neuropathic pain. Physical inactivity due to lower body paralysis rapidly leads to loss of
muscle, and risk of heart disease. The leading cause of death after a spinal cord injury is
cardiovascular disease, and just a year after injury, those with SCI have a peak exercise
capacity half that of the unfit general population.
The good news is that aerobic exercise reduces the risk of chronic metabolic and
cardiorespiratory diseases, reduces inflammation and pain, and increases mood and quality of
life. Exercise can also reduce brain inflammation, enhance endogenous analgesia, and
increases the size of the hippocampus.
The issue is that muscle paralysis in SCI restricts the ability to achieve the levels of exercise
that is necessary for broad analgesic, anti-inflammatory and neuroprotective benefits. Arm
exercise can have some effects on heart and lung capacity, but the small muscle mass is
insufficient to produce more than modest aerobic work. With functional electrical stimulation
(FES), leg muscles that are paralyzed can be made to contract, thereby allowing more of the
body to be exercised. The full rowing stroke is produced by both the (stimulated) legs and arms,
increasing the active muscle mass and resulting in an aerobic work-out that is intensive enough
to improve heart, lung, and – maybe – brain function.
In this clinical trial of sub-acute spinal cord injured subjects, we will study how 12 weeks of FES-
RT, in comparisons to 12 weeks of wait-list, changes pain, brain structure, endogenous opioid
function and brain inflammation.
We will measure changes using positron emission tomography and magnetic resonance
imaging We hypothesize a decrease in pain interference, an increase in hippocampal volume,
increased endogenous opioid transmission in the periaqueductal gray, and decreased
hippocampus neuroinflammation.

Public health relevance
Spinal cord injury leads to brain changes and brain inflammation that persists after the initial injury. Physical activity can mitigate many of these changes, but paralysis restricts patients from intensive full body exercise. This clinical trial will investigate mechanisms through which indoor rowing using electrical stimulation of the paralyzed leg muscles can reduce brain inflammation and pain.